ShEEP Request for SCANCO Medical VivaCT 80 preclinical micro-computed tomography (pCT) system

This application is to acquire a SCANCO Medical VivaCT 80 Preclinical X-ray Micro- computed tomography (pCT) system at the San Francisco VA Medical Center (SF- VAMC) Bone Imaging Core Facility, which was originally established in 2003 by funding from a BLR&D Research Enhancement Award Program and later a BLR&D Program Project Award. This new imaging system will continue to support 11 current VA-funded projects in endocrinology, orthopaedic surgery, and cardiothoracic surgery, and enable new collaborations in the translational research of larger vertebrates.

Public health relevance
The goal of this application is to sustain a critical preclinical animal imaging service to advance our understanding of basic and translational biomedical research in order to improve the diagnosis and treatment of diseases afflicting a large population of VA patients.